Encoding of inflammatory mediators by vagal sensory neurons

Project Summary
The nervous system and immune system communicate with each other to respond to infections
and maintain immune homeostasis. Work over the last two decades has shown that the vagus
nerve is a critical pathway for neuro-immune communication carrying motor signals descending
to the body, in addition to sensory signals ascending to the brain. Detection of immune mediators
in the periphery, such as cytokines, is thought to be vagally-mediated but it is unclear how sensory
neurons respond and represent this information in situ. The goal of the proposed studies is to
discover how vagal sensory neurons encode and represent information about specific
inflammatory mediators. This new understanding will provide crucial mechanistic insights into the
nervous system representation of immune signals, which can be used to understand what goes
wrong in a host of inflammatory disorders that involve immune dysregulation.
With a team of experienced scientists who are experts in the neural regulation of immunity, we
will use genetically encoded calcium indicators to monitor large groups of vagal sensory neurons
while they respond to specific inflammatory mediators. We will use techniques and tools adopted
from neuroscience to determine whether these neurons encode information using a population
code or a temporal code for representing information immune-relevant information.

Public health relevance
Project Narrative The nervous system and immune system communicate with each other to monitor and respond to internal changes and outside threats. Inflammatory mediators present in the periphery must be encoded and signaled up to the brain through sensory neurons, but how this neural representation happens is unknown. Using a novel method to monitor vagal sensory neurons responding to these mediators, we will determine how immune-signals are represented by the peripheral nervous system.